Multicenter Network of Neonatal Intensive Care Units

This is a competitive renewal application to remain one of the cooperating study centers in the Cooperative Multicenter Neonatal Research Network.